Develop new bioinformatics infrastructures and computational tools for epitranscriptomics data

Project Summary
Dynamic mRNA modiﬁcations, such as the m6A-dependent regulation at the mRNA level, add a
critical new dimension to post-transcriptional regulation of gene expression. The rapid development
of sequencing technologies has transformed the ﬁeld of epitranscriptomics studies by resulting in the
successful proﬁling transcriptome-wide RNA modiﬁcations under different states and conditions. They
hold the promise to reveal regulatory machinery of RNA modiﬁcations, which contributes to almost
every phase of mRNA metabolism and function, thereby impacting diverse biological processes. How-
ever, analytical developments in epitranscriptomics lag far behind the pace of technological discovery,
and the bioinformatic infrastructure available for epitranscriptomic studies remains limited. The overar-
ching goal of this proposal is to address three most pressing challenges facing proﬁling and interpreting
epitranscriptomics. Speciﬁcally, we will achieve the following aims: Aim1. Develop statistical methods
for RNA modiﬁcation detection at single nucleotide resolution. Aim 2. Develop computational meth-
ods for cell type-speciﬁc methylation analysis. Aim 3. Develop web servers that enable integrating
RNA modiﬁcation with a rich catalog of genomics features. All the methods will be implemented in
user-friendly software and disseminated to the scientiﬁc community. Successful achievement of all
aims will dramatically increase the power of epitranscriptomes analysis, leading to better understand-
ing of regulatory mechanisms in RNA modiﬁcations and their implications in phenotypes and human
diseases.

Public health relevance
Project Narrative The paradigm-shifting discoveries in RNA modiﬁcations have added RNA to the picture of dynamic regulation of gene expression through reversible chemical modiﬁcations. Successful transcriptome- wide proﬁling of RNA modiﬁcations can signiﬁcantly advance the frontier of epitranscriptomics research and associate epitranscriptomic variations with human health and diseases. The aim of this proposal is to develop bioinformatics infrastructures and computational tools for epitranscriptomics studies.